2020 Pittsburgh International Lung Conference: Metabolism and the Lung: Homeostasis, Immunity, and Disease

ABSTRACT This application requests partial funding for the 2020 Pittsburgh International Lung Conference entitled “Metabolism and the Lung: Homeostasis, Immunity, and Disease.” The Pittsburgh International Lung Conference (PILC) has been a leading meeting in the field of Pulmonary Medicine for more than 15 years. With a focus on the presentation of cutting-edge topics in clinical, translational, and basic research, the PILC brings together leaders from institutions across the country and internationally to participate in thematic discussion and foster collaboration. Previous Pittsburgh Lung conferences have focused on COPD, asthma, acute respiratory distress syndrome, aging, pulmonary fibrosis, personalized medicine, and host defense, among other topics. This year, we will partner with the University Clinic in Barcelona, Spain and the Royal College of Surgeons in Ireland to bring international insights on the role of metabolism as it pertains to Pulmonary Medicine in 2020. This year's Pittsburgh International Lung Conference will include seven thematic sessions structured around lung biology and disease with special attention to the metabolism of the cells and tissues, whole human metabolism and performance, and the microenvironment and microbiome within this complex organ. Our program will feature four keynote speakers, as well as local, national, and international experts. Each session will showcase K-level and early R-level faculty. Division chiefs from Harvard, Penn, Pitt, and Hopkins will moderate a Young Investigator’s panel of presentations. A call for abstracts will provide an opportunity to for all attendees to show their work and to network. Meritorious abstracts will be selected for short talks integrated into the final program. Women and underrepresented minorities will be part of this conference program, and travel awards will be granted to provide balanced numbers of presentations from URM investigators. A special Panel Discussion, “Academic Success as Perceived from Beyond Academia” will feature Editors from top tier journals, NIH stakeholders, and a leader from the American Society for Clinical Investigation. The 2020 Pittsburgh International Lung Conference will not only serve as a forum for cutting- edge basic, translational, and clinical research on metabolism in pulmonary disease, but will also provide guidance and exposure for early and mid-career professionals toward career success.

Public health relevance
PROJECT NARRATIVE Cellular and tissue metabolism is increasingly recognized as contributing to human health and the development of disease. The 2020 Pittsburgh International Lung Conference will convene an international group of expert scientists and clinicians to discuss novel insights into the metabolic basis of lung disease and critical illness, serving to deepen our understanding of human medicine and stimulate collaborative research efforts exploring potential novel therapeutics.